Functionally guided adult whole brain cell atlas in human and NHP

Project Abstract
Integral to all aims of the parent grant (from here on, Human Mammalian Brain Atlas, or HMBA) is a
hospice/palliative care brain donor program which will collect functional imaging data from participants
antemortem to integrate with the whole brain atlas generated postmortem. There are, however, disparities in
access to palliative and hospice care, with people from minoritized racial and ethnic backgrounds less able to
access these forms of care. These disparities have the potential to disrupt HMBA’s ability to meaningfully include
and positively impact people from minoritized groups. This supplement will support post-baccalaureate
researcher Zoë Hale as they assist in designing and facilitating a series of qualitative interviews with hospice
and palliative care workers working within underrepresented minority groups. This supplement will have two
complementary, primary aims: (1) conduct a comprehensive literature review encompassing ethical, moral, and
societal impact of creating a whole brain atlas on minoritized groups; (2) conduct a qualitative interview project
to engage with the views of hospice and palliative care workers in minoritized groups on the ethical and moral
issues related to brain atlasing. These complementary aims will provide HMBA’s hospice/palliative care brain
donor program on best practices for interacting with and meaningfully including individuals from minoritized
communities. This project serves to train and guide Zoë Hale toward a robust career of NIH-supported research
at the intersection of the brain sciences and bioethics. Her plan includes collaboration with professionals across
both the humanities and sciences to enhance her humanist and qualitative research abilities.

Public health relevance
Project Narrative Integral to all aims of the parent grant (from here on, Human Mammalian Brain Atlas, or HMBA) is a hospice/palliative care brain donor program which will collect functional imaging data from participants antemortem to integrate with the whole brain atlas generated postmortem. Disparities in access to palliative and hospice care have the potential to disrupt HMBA's ability to meaningfully include and positively impact people from minoritized groups. This supplement will support post-baccalaureate researcher Zoë Hale as she designs a qualitative interview study to collect the perspectives of hospice and palliative care workers serving underrepresented minority groups.